Project 2 - Bilateral Oophorectomy on Imaging Biomarkers of Alzheimer's and Cerebrovascular Diseases

PROJECT 2: SUMMARY/ABSTRACT Kejal Kantarci, M.D.
The social and economic implications of dementia will be greatest in women because of their longer life
expectancy and resulting elevated risk for dementia compared to men. This risk of dementia in women may be,
in part, modulated by ovarian hormones and modified by the apolipoprotein E (APOE) ε4 genotype. Women
who undergo bilateral salpingo-oophorectomy (BSO) before the onset of menopause have an accelerated
accumulation of multimorbidity, with an increased risk of aging-related neurological diseases including
dementia. How bilateral salpingo-oophorectomy (BSO) influences the risk of dementia remains unknown, but
needs to be addressed, because it is estimated that one in eight U.S. women have their ovaries removed
before reaching natural menopause. The most common pathologies that contribute to cognitive impairment
and dementia in women are Alzheimer's disease (AD) and cerebrovascular disease (CVD). Determining the
effects of BSO before menopause on the risk of dementia would require decades of follow-up; alternatively,
non-invasive imaging biomarkers can potentially assess the effects of an abrupt loss of ovarian hormones on
the risk of AD and CVD pathologies in a shorter time frame. Our goal in Project 2 is to understand the effects
of abrupt disruption of ovarian hormones on AD and CVD pathophysiology in women who underwent BSO
before reaching menopause through imaging biomarkers. We will enroll 100 women with BSO and 100 referent
women that will be drawn from a well-characterized and established population-based cohort. We hypothesize
that imaging biomarkers of AD and CVD pathophysiology will be more abnormal in women who underwent
BSO before reaching menopause, compared to an age-matched referent cohort of women who did not
undergo premenopausal BSO, and that this difference is modulated by APOE ε4. We will further investigate
the relationship of imaging biomarkers with cognitive outcomes as measured in Project 1.The results of the
proposed research will address this problem by applying state-of-the art imaging and cognitive testing in a
population-based cohort of women. Evaluation of this sample of women, whose midlife history of
premenopausal BSO is well-characterized, provides a unique opportunity to clarify the long-term effects of
abrupt ovarian hormonal disruption on the risk of cognitive decline and dementia through imaging biomarkers
of early pathology. For women considering BSO for cancer prophylaxis, the findings will provide critical
insights, guiding their health care decisions.

Public health relevance
PROJECT 2: NARRATIVE Kejal Kantarci, M.D. Women who undergo bilateral salpingo-oophorectomy (BSO) before the onset of menopause have an increased risk of aging-related neurological diseases including dementia. Our goal in Project 2 is to understand the effects of abrupt disruption of ovarian hormones on Alzheimer's and cerebrovascular disease pathophysiology in women who underwent BSO before reaching menopause. For women considering BSO for cancer prophylaxis, the findings will provide critical insights, guiding their health care decisions.